Diversity Supplement: Irma Zenteno

SUMMARY The ability to express different genes in different cell types is crucial to development of a multicellular organism. This cell-­type specific gene expression relies on memory of activation and repression of genes through successive rounds of cell division as the organism develops from an embryo to an adult. An important component of the memory of cellular identity is the cell’s chromatin state. To maintain a transcriptional program, the cell has to maintain accessibility at active promoters and enhancers and occlusion at repressed promoters and enhancers. However, the passage of replication forks during every cell cycle obliterates cell-­type specific chromatin landscapes. Our overarching goal is to determine how chromatin landscapes are sustained in spite of nucleosome dynamics throughout the cell cycle, thus maintaining cellular memory. Here, we will use genomic methods we develop(ed) to identify cellular mechanisms that maintain chromatin landscapes despite the erasing effects of replication. We will pursue two lines of investigations: First, we will identify how transcription factors find their binding sites after being stripped from the DNA during process of replication. We have shown that transcription factors are replaced by nucleosomes genome-­wide post-­replication. By tracking transcription factor binding to DNA and DNA accessibility as a function of time post-­replication, we will uncover the determinants of transcription factor site selectivity. We will also study the effect of chromatin remodeler function in creating transcription factor binding sites post-­replication. Second, we will elucidate cellular mechanisms that maintain repressed chromatin landscapes through replication at epigenetically silenced domains that are characterized by trimethylated histone H3 (H3K27me3), which we call “Polycomb domains”. Polycomb group proteins maintain repressed states at these domains. Mechanisms that carry memory of repression through replication have to act within a single cell cycle, every cell cycle. We will combine tracking chromatin states genome-­wide post-­replication with carefully chosen perturbations of Polycomb group proteins to uncover mechanisms that maintain this repressed state through replication. Taken together, these studies will not only resolve long-­standing questions in transcription factor-­site selectivity and Polycomb repression, but will also serve as a framework to understand how chromatin dynamics can shape genome function in many biological contexts.

Public health relevance
PROJECT NARRATIVE A cell’s identity is tied to how its genome is packaged. This cell type specific genome packaging is essential for normal development of the organism and is frequently disrupted in disease. This proposal will identify how a cell remembers the specific packaging of its genome every time it replicates its genome so as to maintain its identity during normal growth and how perturbation of this memory can lead to aberrant cell states.